PHOTOMETRY FOR PHOTODYNAMIC THERAPY

Dosimetry for photodynamic therapy (PDT) involves measurements of hematoporphyrin derivative (HPD) concentration, oxygen concentration, singlet oxygen, and therapeutic light level, all as a function of position throughout the tissue being treated either intentionally or unavoidably. Noninvasive measurements are essentially limited to surfaces, although theoretical and empirical models can be used to estimate values some distance into the tissue. Fiber-optic probes can be used for direct subsurface measurements.